Chemistry Human Food Track

PROJECT SUMMARY / ABSTRACT The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under FDA funding opportunity PAR-20-105, “Laboratory Flexible Funding Model (U19)”. This summary is for the Chemistry Discipline Analytical Track 2: Human Food Product Testing. The purpose of this track is to improve food testing surveillance programs through the chemical analysis of food products. The test results generated can be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations. As part of this track the MDA chemistry lab commits to analyzing at least 100 human food product samples. Project Summary/Abstract - Minnesota Department of Agriculture